Administrative Core

Administrative Core
Summary
The Program Project Grant (PPG) entitled “Pathogenesis of E. coli and Shigella Infections in
Human Enteroid Models” is supported by an Administrative Core (Core A) to maintain the
communication needed to coordinate the research and financial activities being conducted in the
three separate medical schools - the University of Maryland, Johns Hopkins, and the University
of Virginia – that are participating in this research. The Administrative Core is directed by Dr.
James Kaper, the Administrative Core Leader, with Ms. Sarah Woods serving as the PPG
Administrator. The Administrative Core is located at the University of Maryland School of
Medicine in the Department of Microbiology & Immunology.
The main focus of the Administrative Core is the successful implementation of the program goals
to support a coordinated research program designed to further develop and characterize the
human enteroid model system to study the pathogenesis of E. coli and Shigella infections. The
Administrative Core is integral to the overall goals of this PPG, particularly regarding synergy
among projects. The Research Projects and the other two cores in this PPG, the Enteroid Core
and the Immunology Core, are highly inter-related and each interacts with the others. The
Administrative Core will maintain a stable, flexible, yet centralized infrastructure to promote and
coordinate multi-disciplinary research in infectious enteric diseases involving experts in
gastrointestinal physiology, clinical gastroenterology, vaccinology, molecular and enteric
microbiology, pediatrics and infectious diseases. The leadership team and administrative support
described herein has proven to be very effective and flexible during the first period of support for
this PPG.